In vitro metabolite profiling with vibrational phase-contrast imaging

Project Summary
Cell-based assays are critical in preclinical drug development programs as they provide reliable
predictions of a small molecule chemical compound’s metabolism, pharmacokinetic properties,
and potential as a therapeutic. In vitro metabolite profiling and mapping studies are relatively cost-
effective ways to optimize lead candidates and provide important information for designing
secondary and in vivo assays. Metabolite characterization is achieved using commercial
analytical chemistry instruments, currently led by mass spectrometry, UV/Vis and fluorescence
spectroscopy, however recent advancements in novel vibrational spectro-microscopy methods
with increased sensitivity, resolution, and throughput now offer a compelling technique to non-
destructively profile metabolites while retaining spatial information. The metabolite profiling
datasets our instrument will generate are complimentary to other spatial biology multiomic
platforms and will be very useful for evaluating phenotype. Such technologies will likely have utility
studying tissue section samples and engineered cells used in synthetic biology as well.
Our platform instrument is based on widefield photothermal (PT) microscopy where a tunable
mid-infrared light source is used to excite molecular vibrations. To improve sensitivity at lower
chemical concentrations, we will integrate the PT modality with spatial light interference
microscopy (SLIM), a highly successful quantitative phase imaging (QPI) technique optimized for
speckle-free imaging and nanometer phase sensitivity. We will use a polarization camera to
capture QPI images in a single-frame, allowing true video-rate chemical imaging with sub-micron
resolution. We will compare key metrics of our instrument to the PT microscope in the laboratory
of Prof. Ji-Xin Cheng at Boston University. We conclude this Phase I effort with an in vitro cell
screening demonstration at the University of California, Irvine where we will monitor presence of
the small molecule pyridoxal 5’-phosphate (vitamin B6) in live colorectal cancer (CRC) cells. We
anticipate lower B6 levels in CRCs with hyperactive lysosomes and degraded PDXK enzymatic
activity. These results implicate key roles for vitamin B6 in the processes of cell growth/
proliferation and hint at a therapeutic vulnerability to exploit in CRCs.

Public health relevance
Project Narrative The proposed research will enable an imaging platform designed for fast, high sensitivity, label- free chemical imaging used for in vitro metabolite profiling during preclinical drug discovery programs. This is achieved by combining vibrational photothermal (PT) microscopy with spatial light interference microscopy (SLIM) to acquire speckle-free quantitative phase images (QPI). Such a benchtop instrument could assist in the development of new therapeutics. Thus, the proposed research is relevant to the NIH’s mission to gain knowledge about the nature of living systems and reducing the burdens of disease.